Mechanisms of spontaneous and vaccine mediated hepatitis C virus control to direct rational development of a novel HCV vaccine

Administrative Core A Project Summary
The Administrative Core will provide the administrative support necessary for coordination of research activities
between the five projects and the Scientific Core. The Administrative Core will assist the Center Director,
Scientific Core and Project Leaders by achieving the following aims: Aim 1: To provide the organizational
capacity to coordinate, supervise, and manage all HCV Vaccine Research Program activities, including
integration and coordination of research aims. Aim 2: To provide fiscal oversight and assist Project Leaders
with administrative aspects of their projects. Aim 3: To maintain adherence with human subjects and other
regulatory guidelines. Aim 4: To oversee data management and analysis and manage the data sharing plan.
Through these aims, the Administrative Core will be responsible for: 1) Coordinating, supervising, identifying
and resolving problems, and managing all research program activities, which includes sponsoring activities to
advance the research program’s integration. 2) Providing a supportive structure sufficient to ensure the
accomplishment of all research program goals. 3) Assisting Core and Research Project Leaders with
administrative aspects of their projects, such as gathering of annual progress reports and facilitating other
communications. 4) Promoting collaboration and coordination among Core and Research Project Leaders. 5)
Fostering outreach activities to promote collaborations with the pertinent scientific communities. 6)
Communicating with NIAID and with other awarded research programs regarding collaboration and
coordination of activities and projects.